Kansas Department of Agriculture Laboratory's Implementation of a Laboratory Flexible Funding Model

Kansas Department of Agriculture – Project Summary/Abstract
The Kansas Department of Agriculture Laboratory (KDAL) aims to help create a national,
fully integrated food safety system by expanding our testing capabilities in both
Microbiology and Chemistry disciplines. Additionally, the KDAL strives to increase sample
throughput in both human and animal product testing to grow food safety surveillance
across the state. Participation in capacity development will expand the resources
available at the KDAL to accomplish the goals outlined in this cooperative agreement.
The KDAL serves as the primary servicing laboratory for the Food Safety and Lodging
(FSL) and Dairy and Feed Safety (DFS) programs who have jurisdiction over human and
animal food products manufactured in the state of Kansas. Both the FSL and DFS
programs will collect all human and animal food products that will be analyzed under this
cooperative agreement. The collaboration between the state regulatory programs and the
laboratory will play an integral role in achieving an integrated national food safety system.
The KDAL is dedicated to producing the highest quality testing results and seeks to
identify ways for continual improvement. All employees of the KDAL are familiar with the
quality documentation and are responsible for implementing quality policies and
procedures. Continued laboratory accreditation to ISO/IEC 17025:2017 will allow for a
complete quality system to ensure defensible analytical results are put forth. The
accreditation attests to the competency and technical capabilities of the KDAL to perform
certain tasks and supports traceability of data generated.

Public health relevance
Kansas Department of Agriculture – Project Narrative By participating in this cooperative agreement, the Kansas Department of Agriculture Laboratory (KDAL) aims to successfully expand the testing capabilities in both Microbiology and Chemistry as well as increase sample throughput in human and animal product testing. The principles and requirements of the ISO/IEC 17025:2017 standard will attest to KDAL’s competency and technical capabilities to perform tasks and support traceability of data generated. This cooperative agreement will allow for the enhancement of both human and animal food product surveillance and expand the existing KDA surveillance program to ensure a safer food supply.